Latin America Genomics of Breast Cancer Risk Study (LAGENO-BCR)

SUMMARY/ABSTRACT
Breast cancer is a leading cause of death in the U.S. and a major public health burden as one woman out of
eight will receive a diagnosis in her lifetime. Advances in DNA genotyping and sequencing technologies have
led to the identification of >300 germline variants that contribute to breast cancer risk. However, as of today,
large ‘omics’ studies include women of mostly European ancestry even though preliminary evidence indicates
that there is a clear benefit in studying genetically diverse samples. A genome wide association study (GWAS)
in Hispanic/Latina (H/L) women with one tenth of the number of individuals included in previous studies led to
the discovery of protective variants only present in populations that have Indigenous American ancestry. These
variants significantly add to the predictive accuracy of breast cancer polygenic risk scores (PRS). H/L represent
16% of the U.S. population and in some states, up to 37%. To address the lack of H/L representation in genomics
studies, we have created the Latin America genomics of breast cancer (LAGENO-BC) consortium, which
includes ~28,500 Latin American breast cancer patients and ~32,600 unaffected women from 11 different
countries and the U.S. diaspora. Our goal is to study the Latin American-specific genetic architecture of breast
cancer and develop predictive models that account for variation by ancestry and geography. By combining
existing studies, LAGENO-BC quadruples the prior H/L BC GWAS sample size and consequently, provides the
power required for the discovery of additional variants contributing to breast cancer risk and for improving the
predictive power of PRS for risk stratification in those populations. In the first aim, we propose to discover
susceptibility loci and genes associated with breast cancer in H/Ls by conducting GWAS and ancestry-matched
multi-tissue model-based transcriptome wide association studies with readily available RNA sequence data
(TWASs). These analyses will be repeated for overall risk and subtype-specific risk. In the second aim, we will
use known and new genetic risk variants to improve breast cancer risk prediction using ancestry-aware
approaches and integrating existing models based on non-genetic risk factors. This work is expected to result in
the discovery of new risk variants that are especially relevant to populations with an admixed Indigenous
American ancestral background. In addition, utilizing ancestry-matched and multi-tissue models for TWAS, new
associations linked to ancestry- specific and tissue-specific eQTLs are expected to be uncovered. It is also
expected that PRS scores that incorporate H/Ls variants and assess regional and ancestry heterogeneity will be
more predictive than a one-size-fits-all approach. Beyond the proposed work in this application, LAGENO-BC is
building up a resource that will serve as a foundation for future collaborative studies addressing a broad range
of scientific questions related to breast cancer genetics in H/L populations.

Public health relevance
PROJECT NARRATIVE Breast cancer is a leading cause of death in the U.S. and a major public health burden as one woman out of eight will receive a diagnosis in her lifetime. Large ‘omics’ studies that have been able to identify hundreds of breast cancer risk associated polymorphisms include women of mostly European ancestry even though preliminary evidence indicates that there is a clear benefit in studying genetically diverse samples. The goal of this study is to investigate the Latin American-specific genetic architecture of breast cancer overall and by distinct tumor subtypes, which are associated with differences in prognosis, and test predictive models that combine genetic and risk factor information accounting for variation by ancestry and geography.